Targeting Innate Inflammation Pathways to Treat Ocular Infections

PROJECT SUMMARY / ABSTRACT
Endophthalmitis causes a significant number of cases of blindness worldwide. Efforts to prevent damage
to delicate ocular tissues during infection rely on swift and proper use of therapeutics to rapidly kill organisms
and arrest potentially damaging inflammation. Currently-used antibiotics can kill organisms, but the effective-
ness of anti-inflammatory drugs is controversial. Because the intraocular inflammatory response during
endophthalmitis can damage sensitive and nonregenerative retinal tissue, identifying more effective anti-
inflammatory drugs which counteract or arrest these effects is critically needed.
This new R21 proposal is based on the hypothesis that blocking the activity of innate immune pathways
can protect the eye against the damaging effects of inflammation during bacterial endophthalmitis. The
scientific premise of this work is based on: A) data highlighting the importance of innate immune pathway
activation in the eye during experimental bacterial endophthalmitis, B) the presence of key proinflammatory
mediators as an indicator of innate immune pathway activation in human and mouse eyes during bacterial
endophthalmitis, and C) preliminary data demonstrating that genetic absence or therapeutic blockade of innate
immune pathways arrests damaging inflammation in experimental bacterial endophthalmitis.
We will test our hypothesis in experiments designed to determine the effectiveness of oxidized
phospholipids with clinically-used antibiotics in limiting inflammation during experimental bacterial
endophthalmitis. Our preliminary data demonstrates efficacy of an oxidized phospholipid (OxPAPC) in limiting
inflammation caused by Bacillus, one of the most aggressive ocular pathogens. Because inflammation in
endophthalmitis is driven by innate immune pathway activation, it is reasonable to posit that OxPAPC should
limit inflammation caused by less aggressive pathogens. In addition to formulating a more effective strategy for
Bacillus endophthalmitis by combining OxPAPC with clinically used antibiotics, we will test this strategy in
endophthalmitis caused by S. aureus, a leading cause of multidrug-resistant (MDR) post-cataract surgical,
intravitreal injection, and endogenous cases, as well as in Gram-negative endogenous endophthalmitis (EE)
caused by the ESKAPE pathogen Klebsiella, to probe broad-spectrum usage. Defining the efficacy of OxPAPC
in preventing ocular changes which preclude EE will provide additional data for this anti-inflammatory strategy.
For endophthalmitis patients, ineffective treatment often equates with vision loss. Because
inflammation is a significant component of pathogenesis, arresting this response is critical to protecting the
eye. Our approach is novel for endophthalmitis, high-impact, translational, and will move the ocular
infectious disease field forward by identifying a rational and more effective anti-inflammation strategy. These
studies are a logical outgrowth of our research program, and we are ideally poised to contribute impactful
information which will improve therapeutic options for preserving vision during ocular infections.

Public health relevance
PROJECT NARRATIVE Currently used therapeutics for intraocular bacterial infections include antibiotics (which kill organisms) and anti-inflammatory drugs (whose value for these infections is controversial). This proposal will test the utility of blocking key innate immune pathways to eliminate damaging inflammation during intraocular bacterial infections. The proposed experiments are novel, high-impact, translationally relevant, and will identify whether targeting innate immune pathways with antibiotics is a feasible strategy for treating the eye during intraocular infections.